Training in Systems Pharmacology and Toxicology (T-SPaT)

PROJECT SUMMARY/ABSTRACT
Over the past few decades, our knowledge of the mechanisms by which cells interact with drugs and toxins has
exploded due to new molecular analysis techniques and the application of genomic methods. Accordingly, the
emphasis of graduate education in the disciplines of pharmacology and toxicology needs to shift from a
reductionist view to a systems approach in which doctoral students are comprehensively trained so they can
formulate a strategy to solve important biological questions not only at the molecular, cellular, and tissue levels
but also at the whole-animal level. Systems pharmacology and toxicology describes a field of study that considers
the broad view of drug action. A systems approach using in vivo animal models is necessary to establish efficacy,
safety and the pharmacodynamic/pharmacokinetic profile of candidate drugs but there is a shortage of students
trained in this area. This Training in Systems Pharmacology and Toxicology (T-SPaT) Program is designed for
PhD students in their second year of graduate study pursuing dissertation research projects in the
pharmacological sciences. Trainees (2/year for up to 2 years of support) and 33 Program faculty are drawn from
the Graduate Program in Interdisciplinary Biomedical Sciences (GPIBS) and the MD/PhD Program. The T-SPaT
program will train students to use an in vivo approach to answering relevant questions in pharmacology and
toxicology with emphasis on metabolism, drug design, pharmacodynamics, pharmacokinetics, and signaling.
The rationale for the T-SPaT program is that this type of training will provide students with a much broader
perspective on pharmacology and toxicology that will better prepare them to conduct safe, ethical and rigorous
research as leaders of multidisciplinary research teams in the pharmacological sciences. We will integrate T-
SPaT into PhD training programs already active at our graduate training sites in the Little Rock area that include
faculty/scientists in the Colleges of Medicine, Pharmacy, and Public Health on the UAMS, the Arkansas
Children’s Hospital campus, and at the Food and Drug Administration-funded National Center for Toxicological
Research. The unique focus of T-SPaT is training with in vivo systems pharmacological and toxicological
approaches and concepts. The objective of T-SPaT is to provide in vivo pharmacology and toxicology training
that complement the cellular and molecular training that students receive in their home programs. The training
program consists of didactic training in pharmacology, toxicology, physiology, pharmacokinetics, metabolism,
biostatistics, grant writing, and the Responsible Conduct of Research along with laboratory research using an in
vivo model of human disease. The T-SPaT program will also provide strong mentoring, extensive networking,
and teaching and leadership opportunities for its trainees through its programmatic activities.

Public health relevance
PROJECT NARRATIVE This Training in Systems Pharmacology and Toxicology (T-SPaT) Program is designed for PhD students pursuing dissertation research projects in the pharmacological sciences at the University of Arkansas for Medical Sciences. A systems approach using in vivo animal models is necessary to establish efficacy, safety and the pharmacodynamic/pharmacokinetic profile of candidate drugs but there is a shortage of students trained in this area.